Endometriosis Diagnosis and Subtypes, Reproductive History, and Cardiovascular Disease

ABSTRACT
This diversity supplement application is to support the career development of Dhara Richardson, MSPH. Ms.
Richardson is currently a PhD student in Epidemiology at the Mel and Enid Zuckerman College of Public
Health at the University of Arizona. The parent grant (HL164715) entitled “Endometriosis Diagnosis and
Subtypes, Reproductive History, and Cardiovascular Disease” is a longitudinal cohort study examining how
endometriosis, a benign gynecologic condition, impacts women’s risk of cardiovascular disease, led by MPIs
Dr. Leslie Farland (University of Arizona) and Dr. Karen Schliep (University of Utah). Ms. Richardson is from a
historically marginalized racial background (African American), is a US citizen, and is therefore eligible to apply
for diversity funds. We are requesting three years of funding for her career development to support achieving
her goal of completing her PhD program in Epidemiology and preparing for her subsequent postdoctoral
position. The results of this project will support the completion of her dissertation and enhance the skills
needed to transition to a postdoctoral position and beyond. The overarching goal of Ms. Richardson’s
proposed project is to investigate the association between uterine fibroids, another benign gynecologic
condition, and the risk of cardiovascular disease risk factors while considering race, ethnicity, and fibroids
treatment. Fibroids and endometriosis have hypothesized overlapping etiology and may be synergistic in their
influence on cardiovascular disease risk. Ms. Richardson will contribute to the knowledge base that will support
the goals of the parent grant while completing analyses that will enhance both her training and the findings of
the parent grant. The mentoring and training plan will allow Ms. Richardson to increase her knowledge of
cardiovascular disease epidemiology, reproductive factors in relation to cardiovascular disease, and fibroids
management and treatment, including the unique disparities impacting women with fibroids. Her primary
mentor (Dr. Farland, MPI of parent award) and secondary mentor (Dr. Schliep, MPI of parent award) are
experienced mentors and well-suited to support her professional development in this supplement.

Public health relevance
Project Narrative This diversity supplement will advance the understanding of the association between fibroids, endometriosis and risk of cardiovascular disease risk factors, considering sociodemographic characteristics and reproductive history. Understanding these associations will help improve the identification of women who are at high risk for cardiovascular disease, which may allow for early interventions and ultimately reduce morbidity and mortality.